Innate immune responses to SARS-CoV-2 infection in the olfactory epithelium

RESEARCH SUMMARY
Sudden-onset of olfactory loss has been recognized as a common COVID-19 symptom. The mechanism of
COVID-19 related olfactory dysfunction is unknown. Whether the degree of olfactory deficit is indicative of any
long-term neurological diseases in COVID-19 has not been evaluated. Recent single-cell RNA-seq analyses
revealed that the receptor for SARS-CoV-2, ACE2, is not expressed by olfactory sensory neurons (OSNs) but
are expressed by supporting sustentacular (Sus) cells in the OE. Therefore, Sus cells may be the entry cell
type for SARS-CoV-2 in the OE. SARS-CoV-2 infection in the OE needs to be further characterized. Current
observations indicate that the viral infection is sparse and localized. Widespread olfactory receptor
downregulation has been reported under viral infection suggesting that there might be a distributed viral impact
from localized viral infection in the OE. We hypothesize that widespread Sus cell mediated inflammatory
response, triggered by SARS-CoV-2, is responsible for COVID-19 associated olfactory loss. In this study, we
will characterize inflammatory responses to SARS-CoV-2 in the olfactory epithelium and identify Sus cell
specific cytokine expressions; we will established a primary Sus cell culture system to examine viral
recognition pathways and transcription factors involved in SARS-CoV-2 induced innate immune responses; we
will further determine SARS-CoV-2 infection induced olfactory sensory neuron functional deficits. Through this
study, we will gain mechanistic insight into COVID-19 associated olfactory loss.

Public health relevance
PROJECT NARRATIVE Olfactory loss is reported as an early symptom and predictor for COVID-19. The supporting sustentacular cells but not the olfactory sensory neurons in the olfactory epithelium are permissive for SARS-CoV-2 infection. The goal of this proposal is to better understand the innate responses in sustentacular cells upon SARS-CoV-2 infection and how these responses contribute to olfactory dysfunction.